Development of Smart Flocculants for the Treatment of PFAS Contaminated Water

Project Summary
Per- and polyfluoroalkyl substances (PFAS) are a family of manmade congeners with dual hydro- and oleo-
phobic properties, which is why they have been widely used in firefighting foams, as well as in a multitude of
other products such as food packaging, paints, pesticides, and microelectronics. Given their extensive use, high
water solubility, and resistance to conventional wastewater treatment methods, PFAS have been detected in
public water supplies all over the country causing concern for potential toxic human health effects given their
environmental persistence. Flocculation is a widely used separation technique in the removal of suspended
solids from water and wastewater. However, traditional flocculants (e.g., inorganic salts and polymeric systems)
form aggregate flocs that are usually loosely packed, contain a large amount of water due to their hydrophilicity
and as such, require large settling tanks due to the slow process of separation that is required to collect the
solids. Furthermore, they have seldom been used to remove dissolved species like PFAS. To address these
issues, BAM has developed EnviroFloc: an innovative “smart” polymeric flocculant that consists of a temperature
responsive compound, N-isopropylacrylamide (NIPAAm), modified with cationic co-monomers and/or fluorinated
co-monomers. The combination of these three components results in a polymer which can rapidly capture the
dissolved PFAS molecules and form insoluble solid aggregates at temperatures above the lower critical solution
temperature (LCST) The core advantages of this system include: (1) Low water retention in the sedimented floc:
dissolved PFAS molecules are captured by the dissolved polymer at ambient temperature and then collected
into an insoluble densely packed solid pellet above the transition temperature resulting in a smaller solid waste
stream compared to other remediation technologies. (2) Fast kinetics, flocculation occurs within seconds to
minutes as compared to several hours for other flocculant systems. (3) Relatively low energy input required to
flocculate given EnviroFloc’s LCST being close to ambient temperature. (4) Little-to-no pretreatment needed of
the contaminated stream when applied as secondary treatment for challenging PFAS wastes, RO concentrate,
and IX brine. More specifically, aim 1 focuses on the development of EnviroFloc polymer flocculants for
optimized flocculation performance. Specific Aim 2 will evaluate EnviroFloc regeneration via temperature
assisted solid-liquid extraction to determine removal efficiency and EnviroFloc reusability, and specific Aim 3 will
demonstrate EnviroFloc performance efficiency as a secondary treatment step in multiple case studies (e.g., RO
concentrates and IX brine). Finally, specific Aim 4 will design, simulate, and demonstrate feasibility of a PFAS
treatment unit. This Phase II SBIR project will accomplish the key tasks necessary to prepare for
commercialization of BAM’s EnviroFloc and the associated treatment unit specifically for PFAS water treatment.

Public health relevance
Project Narrative In this project, a “smart” flocculant system is proposed to easily remove per- and polyfluoroalkyl substances (PFAS) from water systems, minimizing settling times and additional dewatering steps found in current flocculant technology. The novelty of the proposed polymer flocculant is that it combines a thermoresponsive compound (N-isopropylacrylamide (NIPAAm)) with cationic and fluorinated co-monomers. These co-monomers provide high affinity for PFAS molecules through a variety of interactions (e.g., electrostatic), which enhances affinity for PFAS compounds and greatly accelerates the flocculation and reduces the water retention in the resulting sediment, ultimately producing innovative smart flocculants with enhanced solid-liquid separation performance for removing PFAS from contaminated water.